VOLT (Vanderbilt Oncology Training Program)

The overall goal of the Vanderbilt Oncology Training Program (VOLT) is to prepare hematology and oncology fellows and other trainees for careers conducting impactful cancer-related clinical, translational, and population science. The objectives of VOLT are 1) to identify and recruit trainees to become top-tier junior investigators in hematology and oncology by providing an advanced training experience, and 2) to develop skills that support this career, including communication, resiliency, team building, and grant management. VOLT will accomplish this by mentored clinical research in oncology and tailored didactics including Master’s degree programs. Through regular meetings with the Program Directors, peer trainees, and mentorship committees, annual retreats, as well as preparation of Individual Development Plans and structured Progress Reports, VOLT trainees gain the skill set required for a successful oncology research career. VOLT has identified an outstanding group of 43 committed, experienced mentors across cancer-related disciplines. Trainees conduct mentored research in three areas: 1) molecular oncology, 2) therapeutic development, tumor immunology, and immunotherapy, and 3) bioinformatics, big data, and cancer outcomes. Trainees are recruited from medical and pediatric hematology and oncology, or other cancer-related disciplines. VOLT is led by two physician scientists, a medical oncologist who conducts translational research and a pediatric oncologist who conducts population science and clinical research. An Internal Advisory Committee representing the range of VOLT research evaluates prospective trainees, and monitors the progress of individual trainees and the program’s success. Metrics for trainee and program evaluation include program completion, retention in research-focused careers, funding success, publication, and impact. An External Advisory Committee, composed of four physician-scientists, provides input into the scientific direction of program, ensures it is meeting national workforce needs and cancer priorities, and monitors progress, accomplishments, and trajectory to further programmatic advancement. Ongoing program evaluation has led to improvements in trainee evaluation and changes in advisors and mentors to reflect greater breadth of research expertise. Our 10 trainees have published 28 manuscripts since their appointment to VOLT. Four have received peer-reviewed grant support, and an additional three have applications under review. Of the five trainees who have graduated, four continue in research-intensive careers. In its first cycle, VOLT has been successful in developing trainees who will lead cancer research and advance cancer care and is well poised to continue this trajectory.

Public health relevance
The Vanderbilt Oncology Training Program (VOLT) is designed to prepare trainees for an oncology career conducting cutting-edge research in basic, clinical, translational and population science. The program provides a personalized and mentored research experience with scholarly activity and focusing on developing key fundamental skills to solidify dynamic careers of research excellence to improve the lives of patients with cancer.